Scholars in Oncology Associated Research (SOAR)

Project Summary/Abstract
With the increasing complexity of cancer care, the rising numbers of diverse cancer survivors in the US
population, and the increasing global burden of cancer, it is critical that Pritzker School of Medicine (PSOM),
one of the most diverse and research-intensive medical schools, prepare a workforce trained to meet these
challenges. While the workforce for the continuum of cancer care is interdisciplinary and inter-professional, to
date, medical education has remained compartmentalized. In our first funding period, we have transformed our
approach to training medical students at PSOM for 21st Century cancer care via the Scholars in Oncology
Associated Research (SOAR) program. In a highly innovative 10-week intensive summer program for
medical students, SOAR successfully enrolled 63 participants (51 NCI funded, 12 PSOM funded in COVID 2020).
Of these, 29% are underrepresented in medicine and 20% did global work. In years when travel resumed, 33%
have been global. The SOAR program successfully inspired nearly 70% of participants to continue their cancer
research, leading to 52 cancer-related conference presentations and 37 cancer-related publications.
SOAR participants had higher research self-efficacy and intent to enter a research career than nonSOAR
peers and a deepening of their commitment to cancer research. We propose to continue SOAR to enroll
12 medical students each year, including 4 who will conduct global cancer research at UChicago Global partner
sites. Each student will conduct interdisciplinary cutting-edge cancer research with strong mentorship by
established NIH funded investigators in our Comprehensive Cancer Center or the Center for Global
Health. In addition, trainees will take part in formal instruction in responsible conduct of research, didactic
lectures on the science of oncology, interdisciplinary tumor boards, research skill development and career
planning activities as well as opportunities for career exploration, networking, and outreach that will increase
their knowledge of cancer and motivate them to pursue further education and training for future careers as cancer
researchers. Trainees will be supported by a tiered mentorship structure that includes Faculty Track Group
Leaders who will be responsible for monitoring progress along milestones of completing their projects and lead
peer mentoring sessions where they learn about each other’s research. Using didactic sessions, experiential
research training in settings that represent the diversity of cancer research, and exposure to national and global
leaders in oncology research across the care continuum, SOAR participants will have a greater appreciation for
the interdisciplinary and interprofessional nature of oncology care and research. With rigorous evaluation and
planning, we will continue to build on our success with SOAR and determine if SOAR participants show a greater
propensity to enter cancer research/oncology careers, while tracking outcomes such as publications, grants, and
entry into academic careers. SOAR will enable PSOM to maintain its tradition of excellence in preparing a diverse
and highly skilled workforce to achieve the promise of precision oncology care and promote global health equity.

Public health relevance
PROJECT NARRATIVE The purpose of this Research Education Training Program, Scholars in Oncology-Associated Research (SOAR), at the University of Chicago Pritzker School of Medicine (PSOM) is to inspire medical students to pursue careers in cancer research through exposure to the full continuum from basic science to translational settings and interdisciplinary collaboration needed to provide patient centered care for the 21st Century. To this end, we designed and implemented a 10-week period of intensive research experiences and related training that are not available through formal NIH training mechanisms. An overarching goal of this renewal application is to build on our success, enhance the program and further provide educational activities that effectively supports training of a physician workforce to meet the nation’s biomedical, behavioral and clinical research enterprise.